Translational control of gene expression during poxvirus infection

Post-transcriptional regulation of gene expression at the level of translation is central to the spatial and temporal control of protein production in many biological contexts, including viral infection. The eukaryotic translation initiation factor (eIF) 4F, which bridges the ribosome to the 5' methylated cap of the mRNA and provides helicase activity to facilitate ribosome scanning, plays a pivotal role in regulating cap-dependent translation initiation and is targeted by diverse viruses. Indeed, with their absolute dependence on their host translation system and the relative ease with which they can be genetically manipulated, viral systems have proven invaluable in the discovery and dissection of basic biological processes and have defined many translational control paradigms that operate in both infected and uninfected cells. However, much remains to be learned about the mechanisms involved in regulating translation initiation, in particular how selective and localized mRNA translation is controled. Vaccinia Virus (VacV) is a member of the poxvirus family of large, double stranded DNA viruses that replicate exclusively in the cytoplasm of infected cells within membrane- bound structures termed replication compartments or viral factories. In this proposal we aim to exploit the compartmentalized replication of VacV, whose mRNAs are capped and polyadenylated similar to their host counterparts, to study mechanisms of translation factor activation and redistribution, and their effects on viral and host protein synthesis. Recently, we have shown that VacV activates PI3K-Akt-mTOR signaling to inactivate translational repressor proteins and enhance the formation of host eIF4F complexes. This is accompanied by a redistribution of core components of eIF4F to discrete regions within viral factories where synthesis of viral proteins is thought to occur. Our preliminary data has identified a viral protein, I3 that binds the eIF4F scaffold protein, eIF4G, and both of these factors colocalize within the same regions of viral factories. Although VacV induces global suppression of host protein synthesis, our preliminary polysome profiling shows that translation of certain host mRNAs not only persists but, in select cases, is increased. We propose to characterize the role of I3 in regulating both eIF4F distribution and localized protein synthesis, and screen for additional viral factors involved in mTOR activation. In addition, we propose to determine the role of eIF4F in the continued synthesis of certain subset of host mRNAs, complementing our studies of eIF4F redistribution and activation by upstream signaling pathways to provide a comprehensive analysis of the role of this cap-binding complex in selective host and viral mRNA translation during poxvirus infection. Overall, these aims will not only provide important insights into the replication of poxviruses, but will also contribute to our broader understanding of general mechanisms of localized and selective mRNA translational control.

Public health relevance
With their absolute dependence on host ribosomes, viruses have evolved a diverse array of strategies to gain control of their host's protein synthesis machinery and thwart host defenses aimed at crippling the synthesis of viral proteins. In this proposal we aim to determine how the poorly understood process of localized translation occurs during poxvirus infection and its role in regulating both viral and host protein synthesis. In addition to advancing our understanding of how these pathogens exploit host functions to replicate, these studies will also provide valuable insights into fundamental mechanisms of translational control of gene expression.